Cancer Genomics Shared Resource

Cancer Genomics Shared Resource Summary
The mission of the Cancer Genomics Shared Resource (CGSR) is to provide Masonic Cancer Center (MCC)
investigators with broad, deep, and affordable access to state-of-the-art genomic services. In addition to
maintaining a world-class suite of genomic instrumentation, the Directors and staff of the CGSR help advance
investigators' science through consultation about technology choices and workflows, including upstream
preparative and downstream bioinformatics and data interpretation steps. The skilled staff can perform all of
the technical components of the work or can collaborate with the investigator's own laboratory staff, providing
training and access to equipment they would otherwise not be able to utilize. CGSR assays range from
conventional cytogenetics to the most current single-cell and next-generation sequencing technologies. These
enable MCC researchers to address critical questions relevant to the etiology, behavior, and treatment of
hematologic and solid tumors. There is no other resource at the University of Minnesota that provides these
services to researchers.
The structure and name of this Shared Resource was changed during the last funding cycle. Specifically, the
Cytogenomics Shared Resource merged with the services of the University of Minnesota Genomics Center
(UMGC) to become the CGSR. The CGSR, co-directed by Drs. Betsy Hirsch and Kenneth Beckman, with
expertise in cytogenomics and molecular genomic technologies, respectively, will simplify navigation by MCC
members through the complex spectrum of genomic assays offered at the UMN. The CGSR will ensure
focused attention on the specific scientific needs of MCC investigators while benefitting from the synergies
resulting from integration with the UMGC which serves the entire University community. In the new CGSR,
there will be an additional PhD-level full-time equivalent (FTE) Research Scientist devoted specifically to
customized work for MCC members, facilitating the development of novel assays, generation of pilot data, and
the advancement of cancer research projects.